Validation of IKKbeta as a therapeutic target for HD

DESCRIPTION (provided by applicant): Huntington's disease (HD) is an autosomally inherited neurodegenerative disorder that is caused by expansion of CAG repeats in exon-1 of huntingtin (Htt). Enzymatic cleavage of mutant Htt protein leads to the generation of neurotoxic, amyloidogenic fragments and is one of the earliest events in HD pathogenesis. The environmental cues and the signaling pathways that regulate Htt cleavage are poorly understood, however. HD is an age-dependent disorder and age-related factors such as the accumulation of DNA damage and neuroinflammation are likely to influence its progression. The IkB kinase (IKK)/NF-kB signaling pathway is activated by these environmental factors and is implicated in the pathogenesis of HD. IKKβ is responsive to DNA damage and mediates inflammatory responses. Our results demonstrate that pre- symptomatic HD mice have elevated IKKβ activity localized to the striatum, while symptomatic HD mice also exhibit elevated IKKβ activity in other brain regions including cortex. Inhibition of IKKβ reduces the neurotoxicity of amyloidogenic fragments of Htt in a brain slice culture model of HD. We also find that IKKβ activation induced by DNA damage promotes caspase-dependent WT and mutant Htt cleavage in post-mitotic human neurons. Genetic and chemical inhibition of IKKβ prevents caspase activation and Htt cleavage, while increasing neuronal resiliency to DNA damage. Recent studies implicate IKKβ in the phosphorylation of N-terminus (Ser13 and Ser16) of Htt. Phospho- mimetic modification of these residues ameliorates disease in HD mice. Preliminary studies from our laboratory and other investigators indicate that IKKβ inhibition promotes the phosphorylation of Htt in neuronal models. Thus, IKKβ is a key regulator of HD pathogenesis and its inhibition may be protective in HD. Moreover, deregulated IKKβ is likely responsible for neuroinflammation, which occurs years before the onset of motor symptoms in patients. We propose to investigate the role of IKKβ in HD pathogenesis in several animal models. We will delete IKKβ in the brains of HD mice and examine whether the lack of IKKβ prevents Htt cleavage, neuroinflammation and thereby ameliorates pathology. Furthermore, we plan to test the efficacy of small molecule inhibitors of IKKβ as potentially novel therapeutics for HD. PUBLIC HEALTH RELEVANCE: Prior results with cultured cells described the role of the key kinase, IKKb, in the production of amyloidogenic, N-terminal mutant huntingtin, as well as in the induction of pro-inflammatory cytokines. These same inflammatory markers accumulate years before the onset of motor symptoms in Huntington's disease (HD) patients. The proposed specific aims will now evaluate the role of IKKb in mutant Htt neurotoxicity and neuroinflammation in mouse models of HD, and test the therapeutic potentials of small molecule inhibitors of IKKb.

Public health relevance
Prior results with cultured cells described the role of the key kinase, IKKb, in the production of amyloidogenic, N-terminal mutant huntingtin, as well as in the induction of pro-inflammatory cytokines. These same inflammatory markers accumulate years before the onset of motor symptoms in Huntington's disease (HD) patients. The proposed specific aims will now evaluate the role of IKKb in mutant Htt neurotoxicity and neuroinflammation in mouse models of HD, and test the therapeutic potentials of small molecule inhibitors of IKKb.